Elucidating and targeting Siglec-9 function on mast cells

PROJECT SUMMARY/ABSTRACT
Mast cells have been recognized as key effector cells in urticaria, mastocytosis, and allergic disease. Specifically,
studies have shown that the dysregulated expansion and/or activation of mast cells have detrimental
consequences in these disorders. Moreover, they have driven the search for effective new strategies to
downmodulate mast cell function. Due to their immunoreceptor tyrosine-based inhibitory (ITIM) motifs, pre-
clinical and clinical studies support Sialic acid -binding immunoglobulin-like lectins (Siglecs) as an attractive
therapeutic target to inhibit mast cell function in mast-associated disorders. However, clinical trials aimed at
evaluating the use of antibodies against Siglec-8, one of the most promising inhibitory receptors for mast cell
targeting, did not meet primary endpoints for treatment of atopic dermatitis and chronic spontaneous urticaria.
These disappointing results highlight the need of our proposed studies to better understand the biology of Siglecs
and their ligands in a complex disease microenvironment that can impact Siglec ability to modulate mast cell
function. Our published studies and preliminary data demonstrate that: 1-Siglec-9 co-engagement with the high
affinity receptor for IgE inhibits human primary mast cell activation, and the severity of systemic anaphylactic
reactions; 2-Siglec-9 on mast cells can attenuate the severity of allergic airway immunopathology; and 3-Siglec-
9 interactions with its ligands in cis promote mast cell quiescence. Accordingly, the overall goal of this proposal
is to test the hypothesis that Siglec-9 and its ligands play a critical role in mast cell homeostasis, and that Siglec-
9 can be targeted to reduce the severity of mast cell-associated disorders. In Aim 1, we will investigate how
Siglec-9 ligand metabolism can modulate human mast cell function in vitro and in mouse models of systemic
anaphylaxis. In Aim 2, we will assess Siglec-9 contribution to modulation of mast cell function in a mouse model
of allergic airway inflammation. We will also examine whether alterations in the expression of Siglec-9 ligands in
airway epithelial cells associate with increased mast cell activation in atopic individuals. In Aim 3, we will examine
whether nanoparticles displaying an allergen and Siglec-9 ligands can inhibit IgE-mediated anaphylaxis and can
desensitize mice for subsequent challenge with the same allergen. Moreover, we will de novo design minibinders
for Siglec-9 clustering to inhibit human mast cell activation.
The proposed studies have the potential to uncover novel biological roles for Siglec-9 and its ligands in mast cell
function. Finally, these studies will lay the groundwork for future projects aimed at exploring the therapeutic
potential of targeting Siglec-9 to modulate disorders in which mast cells play an active role.

Public health relevance
PROJECT NARRATIVE The proposed studies are focused on understanding the role of Siglec-9 and its ligands in mast cell function in health and disease. These studies will be relevant for the development of therapeutics that target Siglec-9 to modulate disorders in which mast cells play an active role.